Exercise-mediated protection against brain metastases

ABSTRACT Clinical evidence indicates that moderate to vigorous exercise is a powerful means to reduce metastatic cancer incidence. However, the mechanisms of this beneficial influence are not fully understood. Our present application is specially focused on the mechanisms of tumor cell extravasation into the brain. Such an emphasis on brain metastases is consistent with our interest in the blood-brain barrier physiology and pathology. In addition, brain metastases are one of the leadings causes of cancer-related morbidity and mortality. The central hypothesis of the present application is that exercise protects against the development of blood- borne brain metastases by increasing antioxidant capacity and modulating redox- regulated responses in the capillary endothelium. To study this hypothesis, we will employ an animal model of wheel running mice that mimics the voluntary pattern of human exercise. We will specifically focus on the exercise-mediated protection against vascular mechanisms of tumor cell extravasation via disruption of tight junction proteins of the endothelium. Tight junctions are the critical components of the brain capillaries which regulate the integrity of the blood-brain barrier. Mechanistically, the main emphasis will be placed on the involvement of the Ras and Rho signaling in alterations of phosphorylation and expression of tight junction proteins. The proposed research combines elements of exercise physiology, clinical approaches (namely, tumor dissemination and growth), cancer progression, and molecular and vascular biology. In addition, we will employ advanced systems biology approaches. Novelty and significance of the present proposal are related to our focus on the blood-brain barrier in brain metastasis, as tumor extravasation occurs at the level of the cerebrovasculature endothelium and the evaluation of the protective effects of physical activity on tumor dissemination and growth. We believe that the data obtained from this proposal will provide evidence that even moderate exercise can significantly protect against the development of blood-brain metastases. Furthermore, a better understanding of the pathophysiological regulation of BBB molecular and functional properties is critical in assessing brain metastasis etiology and in identifying future drug targets to develop more effective therapeutic approaches.

Public health relevance
PROJECT NARRATIVE We propose that exercise can attenuate the formation of brain tumor metastases at the level of the blood-brain barrier (BBB) via antioxidant related mechanisms. Specifically, we will explore the link between exercise and the protection against disruption of tight junction proteins, alterations of caveolae-associated redox signaling, and transcapillary dissemination of tumor cells. We believe that the data obtained from this proposal will provide evidence that exercise can significantly protect against the development of blood-brain metastases. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Moderate to vigorous exercise is a powerful means to reduce metastatic cancer incidence (12- 18). Our present application is specially focused on the mechanisms of tumor cell extravasation into the brain. Such an emphasis is consistent with our interest in the blood-brain barrier (BBB) pathology. In addition, brain metastases are one of the leading causes of cancer-related morbidity and mortality. They occur in 30-40% of all systemic malignancies and contribute to an estimated 200,000 new cases annually (19), a number that is expected to increase dramatically in the coming years. The central hypothesis of the present application is that exercise protects against the development of blood-borne brain metastases by increasing antioxidant capacity and modulating redox-regulated responses in the capillary endothelium. This hypothesis (illustrated in Figure 1) is based on our preliminary data. One of our most important preliminary results indicates that injection of tumor cells (namely D122-Lewis lung carcinoma cells) markedly increases tissue oxidation in brain capillaries and stimulates redox-regulated signaling pathways, such as the Ras signaling. Activation of these signaling cascades can induce phosphorylation of tight junction (TJ) proteins, leading to disassembly of TJs in brain endothelial cells. Indeed, interaction of tumor cells with brain capillaries results in disruption of TJ protein expression. These findings are important because TJs are the main structural elements that influence paracellular integrity of the blood-brain barrier (BBB) and tumor cells extravasate and disseminate into brain tissue via disrupted TJs. Our exciting preliminary results also indicate that exercise can influence glutathione levels and protect against tumor cell-induced oxidative and redox-regulated processes in brain capillaries (Figures 8 and 9). Most importantly, exercise prevents alterations of TJ protein expression in brain capillaries (Figure 12). We hypothesize that these effects contribute in concert to the protective influence of physical activity on the development of brain metastases. Mechanistically, we will explore a link between disruption of TJs and alterations of caveolae- associated redox signaling in brain capillaries during tumor cell extravasation (Figure 1). Caveolae are the subset of lipid rafts that are characterized by the presence of caveolin proteins. Their significance is related to the fact that a variety of cell surface receptors and redox-regulated signaling pathways, including small GTPases such as the Ras and Rho cascades, are localized in caveolae. These pathways may participate in phosphorylation of TJ proteins and influence the opening and closing of TJs. We have evidence that specific TJ proteins are either localized in caveolae or associated with them. Importantly, our data indicate that exercise can modify tumor cell-induced caveolae-associated signaling and regulate levels of caveolin-1 (cav-1) protein. The Specific Aims of the current proposal are (please also see Figure 1): 1. To evaluate the hypothesis that exercise protects against formation of brain metastases by enhancing antioxidant capacity of brain capillaries and limiting transcapillary extravasation of tumor cells. 2. To study the role of the redox-responsive small GTPases in exercise-mediated protection against extravasation of tumor cells across brain capillaries and formation of brain metastases. 3. To evaluate the role of caveolin-1 in exercise-mediated protection against alterations of the redox signaling, transcapillary extravasation of tumor cells, and formation of brain metastases. Tumor cells Caveolae Mitochondrial dysfunction and caveolin-1 G proteins oxidative stress (Aim 3) (Aim 1) RhoA Ras (Aim 2) Alterations of tight junction protein expression Disassembly of cell junctions LOSS OF INTEGRITY OF BRAIN ENDOTHELIUM, TUMOR CELL EXTRAVASATION, DISSEMINATION, AND METASTASIS FORMATION Figure 1. Diagram of the leading hypothesis of the current proposal. A single caveola is illustrated as a membrane invagination. We propose that the interaction of tumor cells with brain capillaries can induce oxidative stress, leading to stimulation of the small GTPases, namely the Ras and Rho pathways. Activation of these cascades leads to alterations of expression of tight junction (TJ) proteins and tumor cell extravasation. We hypothesize that exercise can modulate these events by increasing the antioxidative potential of brain capillaries. In addition, caveolin-1 can modulate the interactions of tumor cells with brain capillaries and thus influence the formation of brain metastases. Solid bars indicate pathways which can be inhibited by exercise. The diagram also illustrates the integration of Aims 1-3. The goals of the present proposal are to answer the following questions: a) What are the underlying, molecular and signaling mechanisms induced by tumor cells in brain capillaries, leading to endothelial dysfunction, disruption of the BBB integrity, and tumor cell extravasation and dissemination? How can exercise protect against these effects? b) What is the contribution of cav-1 in the regulation of the BBB disruption in response to tumor cells? Can exercise prevent the BBB disruption by modulating cav-1 levels in brain capillaries? Aim 1 is focused on the role of antioxidative capacity of brain capillaries in exercise- mediated protection against disruption of the BBB by tumor cells. The emphasis will be placed on establishing the exercise load to achieve the optimal protection against alterations of the BBB properties. The integrity of the BBB will be evaluated by functional assessments of permeability and morphological evaluation of tumor cells extravasation and dissemination in exercised and sedentary animals injected with tumor cells. We expect that these studies will provide proof-of-principle that exercise can attenuate disruption of the BBB and the development of brain metastases. In addition, we will evaluate the effects of tumor cells and/or exercise on oxidative/antioxidative balance in brain capillaries. We will focus on activation of NAD(P)H oxidase (NOX) and mitochondrial dysfunction as prooxidative processes. Evaluation of antioxidant mechanisms will be related to modulation of manganese superoxide dismutase (MnSOD) and glutathione levels. Aim 2 will then concentrate on the mechanisms of alterations of expression and distribution of TJ proteins in response to tumor cells in exercised and sedentary mice. The barrier function of the brain endothelium is controlled primarily by intact TJs. In addition, expression of TJ proteins is regulated by phosphorylation processes. Therefore, studies in Aim 2 will be focused on the effects of exercise on tumor cell-mediated alterations of expression, phosphorylation, and distribution of TJ proteins. We will focus on both the transmembrane TJ proteins (such as occludin, claudins, and junctional adhesion molecules [JAMs]) and accessory proteins (zonula occludens [ZO]- 1 and ZO-2), which link the transmembrane proteins to actin cytoskeleton. Mechanistically, the main effort will be placed on the role of caveolae-localized small GTPases, such as the Ras and Rho pathways, in phosphorylation of TJ proteins. These pathways are regulated by the alterations of cellular redox-status; thus, Aims 1 and 2 are directly integrated. Research in Aim 2 will also include novel targeted proteomic approaches to assess expression and phosphorylation of TJ proteins. In Aim 3, we will evaluate the regulatory role of cav-1 in transcapillary extravasation of tumor cells and formation of brain metastases in exercised and sedentary mice. The oxidative stress processes and redox-signaling as well as specific TJ proteins studied in Aims 1 and 2 are largely localized in caveolae. We postulate that caveolae provide the crucial signaling platform for extravasation of tumor cells and formation of brain metastases. To address this hypothesis, studies planned in Aim 3 will be performed using cav-1 deficient mice and littermate controls with normal cav- 1 expression injected with tumor cells into brain vasculature. Consistent with experiments in Aims 1 and 2, we will evaluate alterations of the redox signaling, disruption of the BBB, and the formation of brain metastases. These studies will provide groundwork for possible targeting of caveolae- associated signaling as the protective means to attenuate the formation of brain metastases. Overview of the model systems: The entire proposal will be based on in vivo model systems, with C57BL/6 mice being used in the majority of the proposed studies. These mice develop a high running activity and are prone to induction of brain metastases. In addition, experiments in Aim 3 will be performed using cav-1 deficient mice. As an exercise model, we will use a voluntary wheel running, which is an established model of endurance exercise for rodents. Brain metastases will be induced by injections of tumor cells into the brain vasculature according to our recently developed technique (1,2). The BBB is formed at the level of cerebral microvessels; therefore, brain capillaries isolated from the exercised or sedentary animals will be used as the main experimental material in this application. This technique is fast and involves very limited tissue processing. However, to better control for artificial oxidation that can be induced by tissue isolation, indicators of oxidative stress and antioxidant protection will be assessed using in situ staining techniques. Important Abbreviations: BBB, blood-brain barrier; cav-1, caveolin-1; FD, FITC-labeled dextran; ICA, internal carotid artery; JAM, junctional adhesion molecule; MnSOD, manganese superoxide dismutase; NF-κB, nuclear factor-κB; NOX, NAD(P)H oxidase; TJ, tight junction; ZO, zonula occludens.